Infant Predictors of ADHD and ASD Symptomology

PROJECT SUMMARY/ABSTRACT
Autism spectrum disorder (ASD) and Attention-Deficit/Hyperactivity Disorder (ADHD) are two of the most
common neurodevelopmental disorders and affect approximately 1 in 54 and 1 in 11 children in the U.S.
respectively with a surprisingly high comorbidity rate of up to 70%. Growing literature suggests that early
intervention can ameliorate symptoms and reduce burden of suffering for children affected by these disorders
and their families. In order for early intervention to be successful, identification of infants at the highest risk for
later challenges is necessary. Social communication deficits, atypical attention, and motor skills challenges have
been implicated in the development of both ASD and ADHD. However, little is known about the specificity of
these features as unique mechanisms related to the development of ASD and ADHD in infancy. Characterizing
the profiles of social communication, attention, and motor skills across infants at an elevated genetic likelihood
for ASD, infants at an elevated genetic likelihood for ADHD, and infants at a low genetic likelihood for both
disorders can provide important information about disorder-specific symptoms of ASD and ADHD.
Understanding transdiagnostic and disorder-specific features of ASD and ADHD will lead to improved screening
tools and tailored interventions. Thus, the present study leverages a prospective, longitudinal design to study
trajectories of social communication, attention, and motor skills and their relation to ASD and ADHD
symptomology throughout the first three years of life. Consistent with NIMH’s Research Domain Criteria (RDoC)
approach to investigation of mental disorders, this study will use physiological and behavioral measures to
assess these constructs. Further, ASD and ADHD symptoms will be assessed on a dimensional basis. Specific
Aim 1 will provide novel information about three phenotypes of ASD and ADHD – communication, attention,
motor skills – in infants at genetic risk to provide an early profile of infant skills across three groups. Results from
this study will provide information about symptoms associated with genetic risk for ASD and ADHD. Specific Aim
2 will investigate a physiological measure of attention as a predictor of ASD and ADHD symptomology. Notably,
this aim will address a gap in current literature concerning the association between attention measured
physiologically and symptoms of ADHD. Finally, Specific Aim 3 will explore trajectories of social communication,
attention, and motor development as predictors for ASD and ADHD symptomology. These research aims will
inform the complex mechanisms implicated in the development of ASD and ADHD symptoms.

Public health relevance
PROJECT NARRATIVE Autism spectrum disorder (ASD) and Attention-Deficit/Hyperactivity Disorder are two of the most common neurodevelopmental disorders and have a surprisingly high rate of comorbidity of up to 70%. Features in early infancy have been associated with both ASD and ADHD diagnoses, such as social communication deficits, atypical attention processes, and motor skill challenges, but understanding of the transdiagnostic and differential features of these disorders is limited. This study will investigate the association between social communication, attention, and motor skills in infancy and symptoms of ASD and ADHD to elucidate early mechanisms underlying the development of these disorders.